Improving Access and Affordability of Adult Hearing Healthcare: Effectiveness of Community-based Interventions in West Central and South Alabama

Abstract
Mounting evidence suggests that hearing loss is associated with social isolation, depression and
cognitive decline. Loss of hearing has become a growing public health concern. For those with no available or
affordable hearing healthcare resources, the negative effects of hearing loss are most likely worse when
compared to those with access to hearing healthcare. By improving access to care for all, we can help to
mitigate the negative effects of hearing loss. The proposal outlined in this application specifically addresses
concerns of NIDCD discussed in RFA-DC-19-001 related to the delivery of effective rehabilitation interventions
in communities, in addition to identifying minimal technology that will achieve success for those who have mild-
to-moderate hearing loss. The long term goals of this line of research are to understand how limited access to
hearing health care affects those who live in persistently poor regions of the state, and additionally, to identify
intervention strategies that will effectively address the needs of those who live in these areas. This individually
randomized group treatment clinical trial will use community-based participatory research (CBPR) to
understand and address the needs of those with hearing loss and their families living in underserved
communities of West Central and South Alabama. The specific aims are to 1) conduct a CBPR needs
assessment that will refine our understanding of specific hearing health care needs for those with no access to
hearing health care in West Central and South Alabama; 2) develop an effective community health advisor
(CHA) aural rehabilitation (AR) training program; 3) identify the effectiveness of personal sound amplification
products (PSAPs) for decreasing hearing handicap and improving speech perception in adults with no access
to hearing health care, and 4) implement an adult aural rehabilitation (AR) program for those without access to
hearing health care to improve PSAP benefit, promote PSAP use and lead to increased quality of life (QOL).
Following the needs assessment and training program for community health coordinators and advisors, an
intervention plan will be implemented consisting of personal sound amplification products (PSAPs) and an
aural rehabilitation (AR) program for adults with mild-to-moderate hearing loss who have no access to hearing
healthcare. It is hypothesized that PSAP use will significantly decrease hearing handicap and improve speech
perception. A second hypothesis is that compared to adults who did not receive the AR program, PSAP benefit
and use will be greater, communication in difficult listening conditions will be better, and QOL will be positively
affected for those who did participate in the AR program. Vital to this project is our state-of-the-art mobile
audiology clinic which will travel to remote areas of West Central and South Alabama, making Alabama
uniquely poised to examine the effects of hearing loss on those who live in completely rural areas and
persistent poverty regions.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will address quality of care issues associated with hearing loss in adults who have mild-to-moderate hearing loss and who have no access to hearing healthcare. This project will identify the needs of adults living in rural communities and will use this information to develop effective intervention strategies to mitigate the negative effects of hearing loss. This information is important to NIH’s mission because it will lead to options that will increase access and affordability of hearing healthcare for adults with mild-to-moderate hearing loss, a specific goal of NIDCD.